Redox basis of diaphragm mitochondrial dysfunction and atrophy in heart failure

Abstract
Diaphragm weakness is a significant health problem in patients with chronic heart failure and reduced
ejection fraction (HFrEF). The topic is relevant because respiratory muscle dysfunction impairs coughing and
predisposes patients with HFrEF to pneumonia, activates the sympathetic nervous system causing cardiac
arrhythmias and peripheral vasoconstriction, and impairs alveolar ventilation during exercise and contributes to
shortness of breath and exercise intolerance. A mismatch in production and scavenging of reactive oxygen
species (ROS), accompanied by oxidative modifications of contractile, mitochondrial, and cell signaling
proteins, is a critical determinant of diaphragm abnormalities in HFrEF. Our previous studies suggest that
putative mechanisms for diaphragm fiber atrophy/weakness, contractile dysfunction, and fatigue in HFrEF are
an impairment in protein synthesis/degradation and mitochondrial dysfunction. Moreover, several studies
indicate that diaphragm abnormalities contribute to exercise intolerance in HFrEF, although this postulate has
never been tested with diaphragm specific interventions. In this proposal, our goal is to identify the redox-
mediated and protein oxidation mechanisms which are causative in diaphragm fiber atrophy and mitochondrial
dysfunction in HFrEF and define the role of diaphragm abnormalities on exercise tolerance in HFrEF. To
achieve this goal, the diversity candidate will perform perform experiments in in two specific aims. Aim 1 will
test the hypothesis that overexpression of specific oxidized protein reductases prevent ROS-induced
impairments in critical regulators of protein synthesis, mitochondrial respiration and H2O2 emission, and
diaphragm contractile dysfunction ex vivo. These experiments will be performed in myotubes and diaphragm
bundles from healthy sham-operated animals (parent award). Aim 2 will determine whether diaphragm
myocyte-specific overexpression of oxidized protein reductases prevent HFrEF-induced impairments in critical
regulators of protein synthesis, mitochondrial function, and exercise intolerance. Aim 2 will also include a
depper analysis of global and redox proteomics focused on regulation of protein synthesis/degradation. The
experiments in Aim 2 will be performed in sham and HFrEF animals (parent award). To gain further insights
into mechanisms of contractile dysfunction, the candidate will perform measurements of single fiber ATPase
activity during contraction. The project is a logical extension of the parent award that will give deeper insights
into the mechanisms of diaphragm abnormalities in HFrEF. Importantly, the project will provide training in
original research covering a broad spectrum of topics (cell biology, redox biochemistry, muscle physiology, -
omics, and translational research) under the supervision of a mentoring team with member at several career
stages career stages (Assistant, Associate, and Full Professor) provide a comprehensive preparation of the
diversity candidate for a career as independent investigator.

Public health relevance
Project Narrative Heart Failure with reduced ejection fraction (HFrEF) affects millions of people and weakness of the diaphragm muscle that is used to breathe. Diaphragm weakness, caused by muscle atrophy and contractile dysfunction, impaired metabolism, and exercise intolerance are significant problems in patients because it contributes to morbidity and mortality. Our goal is to gain a deeper understanding of mechanisms and identify targets for prevention and treatment of diaphragm weakness in HFrEF.